HeartShare: Next-Generation Phenomics to Define Heart Failure Subtypes and Treatment Targets - Clinical Centers

PROJECT SUMMARY
Heart failure (HF) is a critical public health issue that affects over 5 million US adults and imposes an
enormous clinical, social, and economic burden. Over half of individuals with HF have HF with preserved ejection
fraction (HFpEF). Furthermore, HFpEF is highly heterogeneous, and different pathologic mechanisms contribute
to symptoms and poor outcomes in several different subgroups of the disease. Although several largescale
randomized trials have been performed, no pharmacological therapies have been identified that improve
symptoms or clinical outcomes in patients with HFpEF. Our group and others have identified that novel
approaches to deeply phenotyping patients with HFpEF can identify subgroups of patients with HFpEF that are
likely to benefit from targeted therapy.
The overarching goal of the current proposal is to establish a large cohort of deeply phenotyped patients
with HF with a focus on patients with HFpEF. We propose establishing a cohort of 1000 patients across all 4
Penn clinical centers: 700 patients with HFpEF, 200 patients with HFrEF (including 100 patients with mid-range
LV EF, 40-50%) and 100 non-HF patients with hypertension (a suitable control population, given that most
patients with HFpEF have a history of hypertension). We will incorporate comprehensive clinical data,
socioeconomic data (particularly as they relate to social determinants of health), patient-centered data (such as
quality of life and functional status), structural and mechanistic cardiac and extracardiac phenotypes (including
in-lab characterization and innovative ambulatory approaches to data collection) and multi-omics approaches.
The phenotypic data will be complemented by contemporary bioinformatic approaches to enhance our
understanding of human HFpEF.
Our phenotyping protocol will provide the opportunity for cross-sectional comparisons against other
groups above, application of within-group clustering approaches, as well as establishing a comprehensively
characterized large prospective cohort of patients with strictly adjudicated HFpEF for prospective follow-up of
hard outcomes. In these patients, we will assess detailed cardiac and extracardiac phenotypes, electronic health
record data, patient-reported outcomes, aerobic adaptations to exercise, and plasma and urinary proteomics
and metabolomics and micro RNAs. We will also assess key ambulatory phenotypes including innovative
approaches to home blood pressure monitoring, physical activity, sleep duration and quality, and important social
determinants of health. Heart failure outcomes will be prospectively adjudicated, including heart-failure related
hospitalization, death, myocardial infarction and stroke. Our analytic approach will include hypothesis-based
research as well as unbiased discovery approaches that will leverage contemporary bioinformatics tools but will
be subject to expert interpretation by members of the Steering Committee, investigator teams at the other Clinical
Centers, and scientific community at large.

Public health relevance
PROJECT NARRATIVE Heart failure with preserved ejection fraction (HFpEF) is a critical public health issue characterize by heterogeneous pathologic mechanisms that contribute to symptoms and poor outcomes across several different subgroups of patients. Understanding to the heterogeneous nature of HFpEF, randomized trials have been unable to identify pharmacological therapies that improve symptoms or clinical outcomes in patients with HFpEF on a large scale. The goal of the current proposal is to establish a large cohort of deeply phenotyped patients with HF to help with better understanding differential mechanisms of adverse outcomes in patients with HFpEF and identifying subgroups of patients that are likely to benefit from targeted therapy.